Sleep deprivation elevates, and sleep alleviates, oxidative stress in the brain.

Abstract
For reasons that remain unknown, sleep is essential for the reversal of deficits in cognition and performance
that accumulate with increased severity during protracted wake. One of the most robust and reliable
features of sleep is a reduction of cerebral metabolism, manifested by a decline in brain temperature and a
decline in brain glucose and oxygen utilization, relative to wake. It stands to reason that the metabolic down
state is essential for the restorative function of sleep, yet the biochemical basis for this relationship is
uncertain. Oxidative metabolism of glucose fuels neuronal activity. Postmortem assays indicate that
protracted wake produces an accumulation of oxidative stress in the brain. We hypothesize that reduced
glucose utilization in sleep reverses a metabolically-driven shift in the redox status (the balance of
oxidation and reduction reactions) of parvalbumin-positive neurons caused by the high metabolic
demand of these cells in the waking brain. We further hypothesize that this function of sleep is
facilitated in part by an extracellular matrix structure known as perineuronal nets, which serve to
buffer against oxidative stress in metabolically vulnerable neurons. To address these hypotheses, we
will perform a systemic pharmacological manipulations (the oxidation/reduction reaction substrate nicotinic
adenine dinucleotide) known to affect the brain’s capacity to withstand oxidative stress. We will also assess
perform brain region-specific depletion of perineuronal nets. We will assess the effects of these
manipulations, and those of sleep/wake cycle manipulations, on cellular redox status markers, both in real-
time in vivo using intravital microscopy, and post mortem by coupling oxidation assays with cell type-specific
immunochemical markers and histochemical assessment of perineuronal net intensity. We will additionally
measure the effects of the experimental manipulations on electroencephalographic markers for brain fatigue
and sleep need. The anticipated results will establish a causal interrelationship between sleep/wake cycles
and brain redox status, and will identify brain oxidation/reduction reactions as a target for both diagnostic
inquiry and therapeutic intervention in the face of sleep insufficiency.
1

Public health relevance
Narrative Protracted wake results in cumulative deficits in cognition and performance that are alleviated only by sleep. The neurobiological underpinnings for this restorative effect of sleep are uncertain. We hypothesize that sleep reverses shifts in the redox status (the balance of oxidation and reduction reactions) of neurons caused by the high metabolic demand of the waking brain, and that this process is facilitated in part by an extracellular matrix structure known as perineuronal nets, which serve to buffer against oxidative stress in metabolically vulnerable neurons. We will address this hypothesis by measuring the effects of sleep/wake cycle manipulations- in parallel with systemic perturbations of redox status and brain region-specific disruption of perineuronal nets- on electroencephalographic markers for brain fatigue and sleep need, and on neurochemical markers of brain redox status. 1